Integrating the Social Context, Sensory Functioning, and Inflammation in a Longitudinal Study of Cognitive Aging and Alzheimer's Disease and Related Dementias

PROJECT SUMMARY/ABSTRACT
Research into cognitive impairments and Alzheimer’s disease and related dementias (ADRD) suggests that
exposure to enriching or stimulating social contexts – i.e., social complexity – may slow age-related cognitive
decline and delay the onset or progression of ADRD. Most research in this area has considered how social
complexity in either the proximal (e.g., social network, social activities) or distal (e.g., neighborhood) contexts
shape cognition. Additionally, prior research on social complexity and cognition is conducted largely separately
from existing physiological frameworks for understanding cognitive aging and ADRD. Through this K01, Dr.
Alyssa Goldman will integrate existing research on the roles of sensory systems and inflammation in shaping
cognitive decline and ADRD, and examine how these associations are informed by changes in both proximal
and distal social complexity over time. Dr. Goldman’s long-term goal is to lead a social science research program
that uses innovative approaches to better understand the social pathways of cognitive functioning and ADRD.
The K01 Award will support this goal by extending her prior training as a sociologist, developing her
understanding of and skills in: (1) the physiology of cognitive aging, ADRD, sensory functioning, and
inflammation, (2) the objective assessment of cognition, sensory functioning, and inflammation through large-
scale, in-home survey methods, (3) advanced methods for longitudinal analysis, and (4) grant writing and
professional development. In parallel with this training, this project has three research aims: (1) to determine
how changes in exposure to proximal and distal social complexity collectively shape cognition and ADRD, (2) to
determine how proximal and distal social complexity are associated with olfaction, in ways that may shape
trajectories of cognition and ADRD, and (3) to determine how proximal and distal social complexity are
associated with inflammation, in ways that may explain changes in cognition and ADRD. The training and
research goals of this proposal will be overseen by a mentorship committee of accomplished experts in cognition
and ADRD, sensory systems, chronic inflammation, and aging and the social context. This study will generate
new insights on the collective impact of proximal and distal social factors on cognitive decline and ADRD. Further,
this study will examine how social complexity shapes trajectories of olfaction and inflammation as mechanisms
in the relationship between social complexity and cognitive health in a nationally-representative sample of older
adults. These physiological frameworks of cognition and ADRD have yet to be contextualized in terms of social
factors. This study will develop innovative measures of social network change, which are largely undertheorized,
and that can be applied to future studies of cognitive aging and other health trajectories. The training and
research activities of this award will equip Dr. Goldman with the skills to succeed as an independent investigator
of the social context of sensory systems, disease processes, and their relationships with cognition and ADRD.

Public health relevance
PROJECT NARRATIVE Cognitive impairment and Alzheimer’s disease and related dementias (ADRD) are major public health issues in the United States that are expected to burden an increasing number of older adults and their families in the coming decades. This proposal will examine how characteristics of the social context shape trajectories of cognition and ADRD, focusing on changes in social networks, social activities, and neighborhood social infrastructure, and the roles of olfactory functioning and inflammation as potential mechanisms. The results of this project will inform research on the social pathways of sensory and cognitive functioning, and illuminate the social context as a potential site of intervention for preventing or slowing age-related cognitive decline.